Administrative Core

PROJECT SUMMARY - ADMINISTRATIVE CORE
The major objective of the George M. O’Brien Kidney Research Center at Northwestern University (NU-
GoKIDNEY) is to promote and support research into the Discovery of Novel Therapeutics that will transform
the prevention and treatment of kidney diseases and eventually lead to cures. The Administrative Core will
provide overall administrative oversight of the Center. The Director and PI of the Center, Dr. Susan
Quaggin, will be responsible for day-to-day operations and overall management of the Center. She will be
assisted by 2 Associate Directors, Drs. Alfred George and Karl Scheidt, who have primary appointments in basic
science departments and a Center Coordinator, Dr. Venus Onay. This cross-disciplinary leadership team was
selected to enhance and strengthen communication among cores and programs and to promote seamless and
effective inter-disciplinary collaborations, a central goal of the Center. The executive committee will be composed
of the Center Director and Associate Directors, the Center Coordinator, the Core Directors, and Directors of
the Pilot and Feasibility and Enrichment Programs as well as a patient representative. The executive
committee will receive guidance from 4 committees: 1) an Internal Advisory Committee comprised of academic
leaders and content experts at NU, 2) a Chicago-based Advisory Committee comprised of members at other
Chicago-based institutions 3) an External Advisory Committee that will include national and international
leaders in therapeutic innovation and 4) a Diversity and Inclusion Committee. The Specific Aims of the
Administrative Core are to: 1) provide oversight of day-to-day operations of the Center, Cores and Programs
2) set scientific goals of the overall Center 3) provide financial oversight to the Center, Cores and Programs 4)
assess performance and monitor usage of each of the Cores, adding or removing services to keep pace with
scientific discoveries and new advances 5) ensure education and collaborative opportunities are maximized
that are cross-disciplinary 6) oversight of success of Center outreach and lay public and stakeholder
communication via the Center portal nephro-HUB and social media 7) provide oversight of the Pilot and
Feasibility Program 8) monitor effectiveness of education and Enrichment Programs supported by the Center
and Cores 9) evaluate and provide oversight for the Kidney Cure Accelerator initiative in collaboration with
INVO and 10) be responsible for effective interactions with NIH and other NIDDK O’Brien and Kidney Centers.